Clinical Care of Newborns with Prenatal Substance Exposure: A National Study

PROJECT ABSTRACT
Perinatal substance use in the U.S. has increased over the past two decades, with now over 8% of pregnant
people endorsing recent use of a federally illicit substance (including cannabis, opioids, and cocaine). For
newborns with prenatal substance exposure, multiple care practices during the birth hospitalization require
special consideration: 1) approaches to newborn toxicology testing, 2) monitoring and management for
newborn withdrawal symptoms, 3) counseling about human milk feedings, and 4) psychosocial support for
families. Each of these aspects of care may shape the earliest parenting experiences of families, including their
first interactions with the health system as parents. Given the issues of stigmatization and criminalization that
surround perinatal substance use, the quality of care for substance-exposed newborns varies widely, with
Black families and families living in poverty most likely to experience outcomes like child welfare services
reporting and family separation. Further research is needed to identify hospital care practices that are readily
implemented and that improve healthcare quality and equity for substance-exposed newborns. This will be an
explanatory sequential mixed methods study conducted with the Better Outcomes through Research for
Newborns (BORN) Network. Established by the Academic Pediatric Association (APA) in 2010, BORN is the
first and only national practice-based research network that focuses on birth hospitalization care for healthy
term and late preterm newborns. As a network of over 130 hospitals across 40 states and representing 10% of
all U.S. births, BORN presents an ideal opportunity to study newborn care across diverse practice settings that
span the legal and epidemiologic landscape of perinatal substance use. All study aims will be co-conducted
with EMPOWER (Empowering Mothers, Providers, and Others to Weigh in as Experts in Research), a unique
multi-state collaborative of patient stakeholders with lived experience of perinatal substance use and formal
training in research methods. For Aim 1, we will develop, pilot-test, and disseminate a cross-sectional survey to
all BORN Network hospitals (N=131) to delineate the range of care practices related to newborn toxicology
testing, rooming-in, human milk feeding, and psychosocial supports for families, and we will identify common
patterns of care. In Aim 2, we will retrospectively evaluate associations between hospital practices and patient-
level outcomes among a purposive sample of 15 BORN hospitals (N=1,500 substance-exposed newborns).
We will conduct multilevel regression, adjusting for clinical and contextual confounders, with a focus on
differences by payor status and race. In Aim 3, we will assess the barriers and facilitators to implementing high
quality and equitable care for substance-exposed newborns by conducting qualitative interviews and in-depth
policy review at 6 hospitals. We will integrate the quantitative and qualitative findings from all 3 Aims to develop
a set of recommendations for practices and written policies that can be disseminated for implementation
across U.S. birth hospitals.

Public health relevance
PROJECT NARRATIVE This project will study a large network of hospitals across the U.S. to study hospital care for newborns with prenatal substance exposure in collaboration with patient stakeholders who have lived experience with perinatal substance use and recovery. Using multiple approaches for measuring hospital practices and their impact on patient-level outcomes, we will generate novel and important recommendations for improving healthcare equity and overall quality, which are amenable to rapid implementation across U.S. hospitals. Thus, the proposed research is relevant to AHRQ’s mission to produce evidence to improve healthcare safety, quality, and equity for newborns and families affected by prenatal substance use.